Axonal FMRP in Synaptic Development

Project Summary
This project will address the question of how abnormal synaptic development emerges in neurodevelopmental
disorders. Our overall hypothesis is that disorganized synaptic adhesion and delayed functional assembly of
synaptic vesicles (SVs) impair the formation and physiological maturation of presynaptic terminals, which triggers
subsequent developmental deficits in synaptic connectivity and function. We will test this hypothesis in Fragile X
syndrome (FXS), a leading inheritable form of autism and intellectual disability caused by functional loss of
Fragile X mental retardation protein (FMRP). Experimental observations will utilize the evolutionally conserved
endbulb terminals that are readily accessible for in vivo cell-autonomous characterizations in chicken embryos.
We will pursue two specific aims to test several important hypotheses derived from our preliminary studies.
· In Specific Aim 1, we will determine the role of FMRP-regulated synaptic adhesion in presynaptic
terminal formation. We hypothesize that axonal FMRP promotes terminal formation, stabilization, and
selective retraction through developmentally profiled synaptic adhesion. To test this hypothesis, we will
use cell-group specific and temporally-controlled genetic manipulations combined with in vivo live
imaging to identify the exact actions of FMRP-mediated axon transport vs. protein translation in dynamic
terminal turnover. We will also identify FMRP-regulated synaptic adhesion elements in developing
terminals and assess the effects of correcting these elements on FMRP loss-induced presynaptic and
axon alterations.
· In Specific Aim 2, we will determine the role of FMRP-regulated synaptotagmin (Syt) in functional
maturation of presynaptic terminals. Syt1/2 are primary calcium sensors on SVs that trigger vesicle fusion
and neurotransmitter release. We hypothesize that FMRP regulates presynaptic functional maturation by
controlling the timely upregulation of Syt2 in nascent terminals. To test this hypothesis, we will determine
the effects of expressing Syt2 on FMRP loss-induced deficits in SV activity, presynaptic protein
machinery, and glutamate release. We will also determine the interplay between synaptic adhesion
regulation and SV assembly under FMRP control using rescue studies.
Together, these results will identify an origin of defective synaptic phenotypes, a hallmark of neurodevelopmental
disorders. This knowledge is of vital importance because it will help establish a sensitive time window and identify
novel therapeutic candidates for preventing, or at least reducing, the progress of synaptic deficits in FXS and
other neurodevelopmental disorders.

Public health relevance
Project Narrative Synaptic dysfunction is common to neurodevelopmental disorders and is considered a major contributor to behavioral deficits. This study will uncover novel axonal mechanisms that initiate abnormal synaptic development in Fragile X syndrome, by combining cell group specific genetic approaches with in vivo time-lapse structural and functional imaging. The results are applicable in understanding the generation of synaptic pathophysiology in neurodevelopmental disorders.